NIH ADMINISTRATIVE SUPPLEMENT AUTOMATED PEPTIDE SYNTHESIZER ZHUANG

ABSTRACT This supplement is requested to support R01 GM129468: Decoding the non-canonical polyubiquitin chains using chemical approaches. The goal of the parent proposal is to develop new approaches for protein polyubiquitination and subsequent identification and characterization of readers of the noncanonical ubiquitin chains in DNA damage tolerance. The success of this proposal critically depends on the ability to generate modified ubiquitin species that contain reactive linker molecules or unnatural amino acids. Using automated solid-phase peptide synthesis (SPPS) to generate the critical ubiquitin species in sufficiently large quantity will ensure the success of proposed research.

Public health relevance
Decoding the noncanonical polyubiquitin chains using chemical approaches Narrative The ubiquitin proteasome system provides a vast number of targets that can be exploited for therapeutic interventions. Our understanding of the complex signaling mechanisms through the many different forms of ubiquitin modifications, particularly on the noncanonical polyubiquitin chains, is very limited. A understanding of the function and recognition of the noncanonical polyubiquitin chains in the biological processes will not only deepen our understanding of many essential cellular processes, but also open doors to new therapeutic interventions by modulating the signal transduction through ubiquitination.